Investigating the Interaction of a Selective Peptoid Probe and Rpn-13, A Non-Essential Ubiquitin Receptor of the Proteasome

PROJECT SUMMARY
Targeting the ubiquitin-proteasome system has greatly contributed to the treatment of hematological
cancers over the past fifteen years. Despite the success of these proteasome-targeted drugs (such as
bortezomib, Btz) that inhibit the proteasome’s catalytic function, eventual drug resistance and off-target toxicities
demand for alternative therapies to treat patients that become resistant to current treatments or for refractory
cases. To overcome the current challenges, many groups have begun targeting the regulatory subunits of the
proteasome. Rpn-13, a ubiquitin receptor on the proteasome’s regulatory particle, has been one of the most
promising targets as it is not an essential proteasome subunit in healthy cells. Our central hypothesis is that
inhibition of the proteasome’s regulatory function, specifically the Rpn-13 subunit, can overcome Btz-resistant
mechanisms, working as an alternative therapy for multiple myeloma (MM) patients. With current inhibitors
RA190 and KDT-11, Rpn-13 inhibition is observed to be toxic to MM in in vitro and in vivo applications. Since
KDT-11 has been shown to be more selective than RA190, the long-term goal of this research project is to
develop Rpn-13 inhibitors with improved potency and physical properties that bind to the same surface as KDT-
11 and maintain KDT-11’s selectively. The objective for this application is to utilize KDT-11 as a chemical probe
to characterize and to explore its mechanism of action with Rpn-13 and in MM cell lines. To complete this
objective, we propose the following specific aims: (1) To determine the binding site of the peptoid probe KDT-11
on Rpn-13, and (2) to evaluate KDT-11’s effect on Rpn-13 and apoptotic pathways in MM and Btz-resistant MM.
Peptoids, such as KDT-11, have been considered potential therapeutic agents but previously reported peptoid
probes have not been further investigated or optimized either due to low-affinity or non-selectivity. This proposal
is innovative, in our opinion, because we plan to transition a selective peptoid probe with modest affinity to a
more lead-like scaffold to develop more potent and pharmacologically-amenable Rpn-13 inhibitors. This
contribution is expected to be significant because the discovery of KDT-11’s binding site and the evaluation of
its mechanism of action in Btz-resistant MM would allow for optimization of the only reported reversible selective
inhibitor for Rpn-13, which would lead to a greater understanding for alternative targets for MM treatment.

Public health relevance
PROJECT NARRATIVE Targeted therapies that inhibit the proteasome’s catalytic activity have significantly contributed to the treatment of hematological cancers over the past fifteen years, but patients are prone to develop resistance to this therapy or still encounter off-target side effects. To circumvent these challenges, many groups have shifted their focus to targeting the regulatory subunits of the proteasome, which has been demonstrated to have a wider therapeutic window, more selectivity for diseased cells over healthy, and could potentially overcome resistance of current therapies. This project will investigate and highlight the biophysical, structural, and cellular properties of an exciting target, Rpn-13, for inhibiting proteasome regulatory particle as an eventual alternative hematological cancer therapy.